IMPACT OF BLAND DIET ON CHEMOTHERAPY INDUCED NAUSEA AND VOMITING

This is a companion to protocol 907. Its purpose is to compare the effectiveness of a bland diet as compared with an unrestricted diet in reducing nausea and vomiting during chemotherapy.